THE T-CELL RECEPTOR'S ROLE IN T-CELL LYMPHOMA PATHOGENESIS

The majority of patients afflicted with a T-cell lymphoma (TCL) will experience disease progression and ultimately
succumb to their disease, as current therapies are rarely curative, and the underlying mechanisms driving TCL
progression and chemotherapy resistance are poorly understood. We have demonstrated that antigen-
presenting cells, particularly lymphoma-associated macrophages (LAM) are abundant constituents of the tumor
microenvironment (TME) in TCL, and directly promote the growth and survival of primary TCL cells ex vivo.
Blockade of the major histocompatibility complex (MHC), required for antigen presentation and T-cell activation,
inhibits LAM-induced proliferation of malignant T cells. Conversely, direct stimulation of the T-cell receptor (TCR)
on primary TCL cells culminates in the activation and upregulation of transcription factors that promote the growth
and survival of conventional T cells, including the zinc-finger transcription factor GATA-3. We have recently
shown that GATA-3 identifies a molecularly and clinically distinct subset of TCL that are highly resistant to
chemotherapy. Genetic and pharmacologic loss-of-function (and gain-of-function) strategies further
demonstrated that GATA-3 confers resistance to chemotherapy. Collectively, our preliminary data are consistent
with the hypothesis that TCR signaling and GATA-3-dependent gene expression are exploited by malignant T
cells and promote chemotherapy resistance. A paucity of TCL models amenable to genetic manipulation and
pharmacologic in vivo studies has hampered further progress. Therefore, the extent to which antigenic
stimulation and GATA-3-dependent gene expression promote T-cell lymphomagenesis and chemotherapy
resistance within the native tumor microenvironment, and within the context of a genetic landscape resembling
human TCL, remains uncertain. We have identified novel, and clinically achievable, therapeutic strategies
targeting the TCR, and we aim to extend those earlier findings here using primary TCL cells and patient-derived
xenografts (PDX). Our long-term goals are to understand the role of antigen-presenting cells, and other
constituents of the TME, in promoting T-cell lymphomagenesis; to identify the lymphomagenic factors they
provide, including those that are antigen, costimulatory, and cytokine receptor dependent; and to develop novel
therapeutic strategies exploiting these vulnerabilities that will improve outcomes for patients afflicted with these
NHL. Our overall objective here is to determine the mechanisms by which the TCR and GATA-3 promote T-cell
lymphomagenesis in vivo. This will be achieved by addressing our central hypothesis that TCL progression,
including resistance to chemotherapy, is regulated by TCR- and GATA-3-dependent transcriptional programs.
This hypothesis is well grounded in our own preliminary data, and is entirely consistent with our current
understanding of the genetic landscape and molecular pathogenesis of the TCL. We anticipate that the research
proposed will provide a strong scientific rationale for novel therapeutic strategies that will ultimately be tested in
well-designed clinical trials.

Public health relevance
PROJECT NARRATIVE (from the parent grant application) T-cell lymphomas (TCL), comprising 10-15% of non-Hodgkin lymphomas (NHL) in North America, are molecularly heterogeneous, poorly understood, and are associated with poor clinical outcomes. Most patients will develop recurrent or refractory disease that is resistant to currently available therapies. In an effort to better understand mechanisms that promote TCL pathogenesis and identify rational and clinically translatable therapeutic strategies, we will investigate the role of the T-cell receptor and the transcription factor GATA-3 in a genetically engineered TCL model and primary patient specimens using complementary genetic and pharmacologic approaches.